Understanding Vision Impairment in ESKD to Prevent Cognitive Impairment and Dementia/Alzheimer’s disease: the VIS-HD Cohort Study

Vision impairment impacts ~60% of the 802,000 patients with end-stage kidney disease (ESKD) in the US, and
evidence in community-dwelling older adults suggests that vision impairment is a potentially modifiable risk
factor for cognitive decline and dementia/Alzheimer’s disease (AD). Identifying and understanding modifiable
risk factors for cognitive decline is a priority in geriatric nephrology: 87% of ESKD patients have abnormal
cognitive function, resulting in a 21-25% lifetime risk of dementia/AD that is 19-fold higher than age-matched
community-dwelling adults. We seek to address 3 knowledge gaps surrounding vision impairment among
patients living with ESKD: 1) prevalence, risk factors, and causes/reversibility of vision impairment; 2) cognitive
and vision-related sequelae; and 3) vision screening and treatment barriers. First, the true prevalence of vision
impairment in ESKD patients is unclear. Refractive errors are common in the general population and small
studies suggest that 29-67% of ESKD patients have diabetic retinopathy and 32-80% cataracts. Vision
impairment is reversible in 90% of the general population; however, in ESKD vision impairment may be due to
retinal damage from vascular disease and diabetes that is unlikely to be reversed. Second, while there is
strong evidence of an association between vision and cognitive impairment among community-dwelling older
adults, this association is unclear among ESKD patients. Vision impairment directly alters brain structure and
reduces cognitive stimulation, and indirectly impacts dementia risk by causing social isolation, depression, and
physical inactivity, all of which are common in ESKD. It is likely that the high prevalence of vision impairment
may contribute to incident dementia/AD and other vision-related sequelae. Third, eye disease is
underdiagnosed and undertreated in ESKD. Vision impairment may be uncorrected given the high burden of
hemodialysis and negative social determinants of health borne by ESKD patients. Identifying screening and
treatment barriers will help inform interventions to correct vision impairment and ultimately improve the lives of
patients living with ESKD. We will leverage the infrastructure of our ongoing intradialytic interventions trial to
launch the Vision Impairment Screening in Hemodialysis (VIS-HD) prospective cohort (n=300). Using an
efficient study design in which all research will be conducted at 16 dialysis centers, we will assess visual acuity
and test for retinopathy during dialysis, then develop interventions to mitigate vision impairment. We seek: 1)
To characterize vision impairment prevalence, risk factors, and causes; 2) To identify cognitive and vision-
related sequelae of vision impairment; and 3) To identify barriers to correcting vision impairment and develop a
multi-modal intervention to mitigate vision impairment. This project will set the groundwork for a subsequent
multi-center randomized control trial to correct vision impairment. Our findings will have an immediate impact
on the lives of the ~802,000 adults who live with ESKD. With this project, we seek to address a NIA priority: To
develop interventions for treating, preventing, or mitigating the impact of age-related conditions.

Public health relevance
PROJECT NARRATIVE Only 13% of the 780,000 adults living with end-stage renal disease (ESKD) have normal cognitive function resulting in a 21-25% lifetime risk of dementia/Alzheimer’s Disease (AD). Vision impairment may be a modifiable risk factor for cognitive decline and dementia/AD and is estimated to be present in 60% of ESKD patients undergoing hemodialysis. We seek to: 1) characterize vision impairment prevalence, risk factors, and causes/reversibility among patients with ESKD; 2) identify cognitive and vision-related sequelae of vision impairment in ESKD; and 3) identify barriers to correcting vision impairment and develop a multi-modal intervention to mitigate vision impairment in ESKD.